Virus-host interactions underlying species specificity of influenza A virus gene expression

PROJECT SUMMARY
Devastating influenza A virus (IAV) pandemics arise when non-human adapted strains overcome human species
barriers to successfully infect and sustain human-to-human transmission. The novelty of a pandemic strain poses
a substantial burden to human health leading to increased incidences of severe respiratory complications,
hospitalizations, and death when compared to seasonal influenza. The most recent pandemic in 2009 (pH1N1)
arose from a reassortant swine IAV that contained human, swine, and avian adapted gene segments. To
understand how these pandemic IAVs overcome species barriers, we must understand the mechanisms that
lead to viral adaptation to human hosts. Recent work in our lab has demonstrated that regulation of gene
expression from the IAV M segment plays a role in host adaptation. The IAV M segment encodes two major
proteins by alternative splicing. Matrix 1 (M1) gives the virion its structure and is encoded by the colinear mRNA,
and M2, which is needed for viral replication, is encoded by a splice product of the M1 mRNA. We have used
reverse genetics to engineer recombinant viruses that share seven of the eight IAV gene segments but differ in
the origin of the M segment, allowing us to evaluate properties of this segment. Recombinant viruses carrying
avian or human adapted M segments replicate to similar titers and express similar levels of M1 and M2 protein
when infecting avian cells. However, in human cells, the avian M segment virus replicates less efficiently and
expresses significantly higher levels of M2 mRNA and protein than the human M segment virus. Mammalian
adapted M segments maintain low levels of M2 in human cells. These data lead to my hypothesis that,
following introduction into mammalian hosts, mutations to the avian IAV M segment are needed to re-
establish optimal virus-host interactions important for regulation of M2 expression. In Aim 1, I will map
the M sequence determinants that underly differential M gene expression between avian and mammalian
adapted M segments. I have used reverse genetics to generate avian M segment viruses that carry nucleotide
mutations identified in the pH1N1 M segment. I will infect human cells with these viruses. Then I will evaluate
the impact of these mutations on avian and human adapted M1 and M2 mRNA and protein steady state levels
and stability. In Aim 2, I will investigate the role of host factors in differential M2 expression between avian and
human adapted M segments. I will determine the binding affinities of avian and human M1 mRNAs with host
splicing factors using biochemical methods and evaluate subcellular localization of M1 and M2 mRNAs during
infection by microscopy. Through these experiments, I will elucidate the molecular mechanisms that underly the
species specificity IAV M segment gene expression. These studies will reveal additional mechanisms of IAV
adaptation to human hosts, which could be used to better assess the pandemic risks of future IAV zoonoses.

Public health relevance
PROJECT NARRATIVE Influenza A viruses (IAV) that arise from animals and infect humans can cause devastating pandemics. Our preliminary studies show that one specific segment of the IAV genome may have a critical role in facilitating animal IAV adaptation to humans. The research proposed here will help to understand the mechanism of animal IAV adaptation to humans, which is crucial to assessing the risks posed by IAV zoonoses.